Impact of obesity treatments on subsequent pregnancy outcomes

PROJECT SUMMARY
Obesity continues to increase in the United States and anti-obesity drugs are being heavily promoted. As a
result, even though treatment guidelines recommend lifestyle interventions as a first-line treatment, and despite
the safety and efficacy concerns around some anti-obesity drugs, prescription of these agents is on the rise.
The obesity epidemic affects young women and spills into pregnancy. In fact, obesity is one of the most
common medical complications in pregnancy, known to increase the risk of multiple adverse perinatal
outcomes. Although anti-obesity drugs are not recommended to women planning pregnancy, pregnant women
are exposed because half of pregnancies are unplanned, and those already using a drug may have no time to
discontinue before organogenesis. Yet, little is known about the current utilization of anti-obesity treatments
around conception or about their effects on the pregnant mother and the developing fetus. Data is needed to
inform the risk-benefit trade-offs and facilitate evidence-based decision-making in obese women with
reproductive potential. Since randomized trials to define the impact of these agents in pregnancy are not
realistic, we need timely information based on carefully conducted large observational studies.
Our primary objective is to quantify the effectiveness of specific anti-obesity drugs on reducing obesity-
related pregnancy complications when used before conception; and their safety when used during pregnancy
intentionally or unintentionally. By harnessing the power of real-world data, we aim to quantify the relative risk
of a broad spectrum of obstetric and neonatal outcomes in relation to specific anti-obesity treatment strategies.
We have established a cohort of 1.3 million pregnancies linked to infants with longitudinal information on
prescriptions and clinical conditions within a population-based health care database (MarketScan). The study
population will include over 100,000 obese women with a pregnancy in 2011-2025. Drug exposure will be
determined based on pharmacy dispensing records, and outcomes will be based on in- and outpatient
diagnoses and procedures, adhering to validated definitions. The study protocols will emulate hypothetical
target trials, which restrict the population to those eligible for the intervention and incorporate active reference
groups. Rigorous measures will be employed to further mitigate confounding, including propensity score
weighting. Absolute risk differences and their 95% confidence intervals will be estimated through generalized
linear models, with innovative quantitative bias analyses conducted to test the findings' robustness. Our
proposal benefits from the collective experience and established track record of a multidisciplinary team, and
our prior work and preliminary results attest to the project's feasibility. Ultimately, completion of this research
will contribute information to our understanding of the risks and benefits of anti-obesity medications in women
with reproductive potential, inform clinical guidelines and pregnancy safety narratives in drug labels, and
potentially provide reassuring evidence to patients accidentally exposed during pregnancy.

Public health relevance
PROJECT NARRATIVE Obesity is one of the most common medical complications in pregnancy in the United States. Use of anti- obesity drugs in preparation for pregnancy may reduce the risk of adverse obstetric and neonatal outcomes, however, their safety for the developing fetus when use continues into pregnancy is unknown. Therefore, it is critical to evaluate the risks and benefits of anti-obesity medications in a large cohort of pregnant women with a diagnosis of obesity, and their infants.